Aging-induced nucleolar decline and chromosomal instability

Project Summary.
Heterochromatin consists of large domains of repetitive DNA such as centromeres, telomeres, rDNA,
and retrotransposons that remain organized into compact chromatin structures throughout interphase,
when other portions of the chromosomes (euchromatin) usually decondense. Heterochromatin is
generally repressive to transcription and plays important roles in maintaining genome stability, whether
it is through facilitating centromere function, telomere protection, or suppressing recombination
between the underlying DNA repeats to help maintain genomic integrity. Such is the case with the
rDNA locus, a relatively understudied and unusual form of heterochromatin consisting of tandemly
repeated rRNA genes. Paradoxically, the rDNA is heavily transcribed by RNA polymerase I (Pol I) to
synthesize ribosomal RNA, yet retains several key heterochromatin characteristics such as suppression
of recombination and “silencing” of RNA polymerase II (Pol II)-dependent transcription. In budding
yeast rDNA, transcription of non-coding RNAs from the intergenic spacers must be silenced by the
conserved NAD+-dependent histone deacetylase Sir2 to maintain rDNA stability and support replicative
lifespan. Remarkably, silencing of these non-coding RNAs by Sir2 actually requires Pol I-dependent
transcription of the large rRNA coding genes. Therefore, the nucleolus has a rather complex and
dynamic chromatin environment designed to optimize rRNA synthesis while maintaining integrity of the
tandem array. During replicative aging of budding yeast, the Sir2 protein, along with the cohesin
complex, and other nuclear proteins, are progressively depleted as the cells get older. This results in
deterioration of the rDNA heterochromatin and instability of the array. Interestingly, the replicatively
aging cells also have a chromosome instability (CIN) phenotype that is driven by the rDNA instability.
Overexpression of the Mcd1 subunit of cohesin suppresses the age-induced rDNA and CIN
phenotypes, and strongly extends lifespan. The experiments in this project are designed to identify
determine how stabilization of the rDNA array by SIR2 and cohesin leads to improved fidelity of
chromosome segregation. We hypothesize that rDNA interactions with the genome, including
centromeres, play a significant role in the age-induced CIN phenotype. Therefore, we will develop a
method to define genome-wide rDNA contacts, and test how these contacts change with age or when
rRNA synthesis is compromised. Mechanistic experiments will also address why certain nuclear
proteins are depleted or destabilized with aging, and identify additional dose dependent longevity
factors. We anticipate these studies in yeast will provide a paradigm for future structural-function
studies of rDNA heterochromatin during aging in mammalian cells.

Public health relevance
Narrative. Genetic instability is one of the hallmarks of aging observed in a wide array of organisms ranging from yeast to humans. This proposal is focused on chromosomal instability (CIN), a type of genetic instability in which either whole chromosomes or parts of chromosomes are duplicated or deleted. We have identified a mechanism of CIN in replicatively aging yeast cells that is primarily caused by progressive depletion of cohesin, a multi-subunit protein complex that holds newly replicated sister chromatids together until the point in mitosis when they are separated and segregated into daughter cells. We hypothesize that preventing CIN in renewing cells is important to support longevity. Therefore, understanding the mechanism of cohesin depletion and how the depletion of additional factors contributes to the age-associated CIN phenotype will provide new targets for interventions that promote organismal healthspan.